Comparative Medicine and Translational Research Training Program

CMTRTP Abstract
The National Research Council has documented a dire national need for veterinary
specialists trained in biomedical research. Furthermore, veterinary researchers play a key
role in comparative and translational research activities since they naturally bridge basic
and clinical research. To address this training need, we request continued NIH funding
for 7 fellows per year for 3 years. NC State University will provide funding for up to 2
fellows per year and 2 pre-T32 positions. Trainees will be degree-seeking fellows in the
Comparative Medicine and Translational Research training program established by the
faculty in the College of Veterinary Medicine (CVM) and the Comparative Medicine
Institute (CMI) at North Carolina State University. This training program specifically targets
individuals with the DVM degree who have completed specialty training and is designed
to prepare trainees to compete for an early career development award and a rapid
transition to independence as a principal investigator or in another research-intensive
career. Trainees complete requirements leading to the PhD degree in Comparative
Biomedical Sciences (CBS) in one of 7 areas of concentration: 1) Immunology 2) Cell
Biology, 3) Pharmacology, 4) Neurosciences, 5) Infectious Diseases, 6) Population
Medicine, and 7) Pathology. Training faculty are well-funded productive scientists that
have a strong training track-record and diverse research expertise. Training faculty are
all members of the CBS graduate program and the CMI and represent 4 departments from
2 Colleges. Research projects emphasize comparative and translational themes fostered
by the CVM and CMI in tissue engineering, pharmacology and physiology, genetics and
genomics, and emerging infectious diseases. Program requirements include: (1) a
capstone comparative medicine and translational research seminar course; (2)
professional development courses and workshops; (3) a course in research ethics; (4) a
grant writing course and a pilot grant program that provide a pathway to a K award; and
(5) annual research symposia. These requirements are in addition to those associated
with the graduate program. Sixteen fellows have completed training. Thirteen hold faculty
positions in academia, one is a research pathologist, and two are research fellows at other
institutions. Fellows were awarded 7 NIH or other career development grants and 15
extramural research grants and published 67 papers (48 first author) arising from their
research while in training.

Public health relevance
Narrative The NC State training program in Comparative Medicine and Translational Research addresses two critical national needs in biomedical research. First is the growing need for veterinarians with training in biomedical research. Second is that more emphasis needs to be placed on translation of basic research advances to the clinical setting and this often requires a multidisciplinary approach.